Kids First Data Resource Center (KFDRC): Harnessing Data-Driven Opportunities in the Present on behalf of the Future of Common Fund Data Ecosystem (CFDE)

Rationale for Multiple PI Proposal This proposal focuses on activities and collaborations with an initial set of Common Fund DCCs and the CFDE-CC in response to the Engagement Opportunity “Engaging Common Fund Data Coordinating Centers to Establish the Common Fund Data Ecosystem (CFDE)” OTA-20-2005. Our proposed engagements span the 3 key areas defined in the OT EOA and include GTEx, LINCS, HUBMAP, and SPARC as well as the activities the Kids First DRC is leading as part of the NIH Interoperability Working Group to further the establishment of the Common Fund Data Ecosystem (CFDE). The four investigators collaborating on this proposal have distinct professional backgrounds, areas of expertise, and research tools at their disposal including leading the Kids First DCC/DRP and CAVATICA efforts. At the Children’s Hospital of Philadelphia, Dr. Adam Resnick is a cancer and neuroscience research scientist with expertise in pediatric brain tumors and Dr. Allison Heath is a computer science expert in large-scale data bioinformatics and compute infrastructure. These experts will work together to lead the CHOP project team. At Centre Hospitalier Universitaire Sainte-Justine, Dr. Vincent Ferretti develops bioinformatics software for both large-scale software development and computational genomics. At Seven Bridges, Dr. Jack DiGiovanna is an expert in cloud-based analysis platforms for bioinformatics that are scalable, collaborative, and reproducible. Responsibilities of Investigators All PIs will share responsibility for ensuring the ethical conduct of the project, upholding the scientific integrity of the project, administration, oversight and coordination of the project’s management. Dr. Adam Resnick will serve as the contact PI. He will be responsible for the overall strategy, determining the prioritization of scientific use cases, and ensuring that the project meets its goals of scientific impact. Dr. Heath will oversee and facilitate the completion of the technical milestones and deliverables across all CDFE engagements. Dr. Heath will also be responsible for the execution of interoperability strategies with CFDE and the NIH IC Stacks. Dr. Ferretti will supervise the KFDRC portal development team and will be responsible for all of their relevant deliverables, such as authentication with NIH RAS and visualization integrations with LINCS. Dr. DiGiovanna will supervise the CAVATICA development team and will be responsible for all of their relevant deliverables, such as GA4GH DRS integration and multi-cloud capabilities. Communication and Data Sharing The PIs will communicate weekly and hold monthly teleconferences with PIs at the other organizations to discuss the CFDE and all administrative responsibilities. In addition, PIs will meet in person with all personnel at least annually to assess progress and make major decisions about the direction of the program. If changes are warranted, PIs will work together to discuss those modifications and the redistribution of funds, if necessary. A publication policy will be established based on the relative scientific contributions of the PIs and key personnel. Dr. Resnick will serve as contact PI and be responsible for submission of progress reports, annual reports to the NIH and all other communication.